Chemical Approaches to DNA Topoisomerase Inhibition and Function

DESCRIPTION (provided by applicant): DNA topoisomerases (Topo) are essential enzymes required to maintain the superhelical topology of genomic DNA during the processes of DNA replication, transcription and chromosome segregation. All topoisomerases are united by the mechanistic feature of using an active site tyrosine to attack the DNA backbone and form a dynamic covalent phosphotyrosine linkage and flexible strand nick that is of extraordinary importance in DNA metabolism and pharmacology. Topoisomerases have long been targets for drugs that bind to and stabilize the covalent complex, but mechanistically novel classes of compounds have not been discovered in more than two decades. This competitive renewal seeks to elucidate how the dynamics and mobility of the enzyme DNA covalent complex facilitate the various DNA transformations catalyzed by the enzyme, including drug binding. We also aim to develop a chemical platform to discover new classes of small molecule ligands that inhibit or poison human, bacterial and parasite type I Topo's. The significance of this work is linking the essential dynamic features of these enzymes to biological function and drug action. The aims are to: (i) Understand how the dynamic mobility of the topoisomerase IB DNA complex leads to supercoil relaxation and drug inhibition. The free strand rotation model for DNA relaxation by Topo IB requires that the DNA segment 3'to the covalent attachment is transiently released from its noncovalent interactions with the enzyme to allow rotation of the DNA around the superhelical axis. Using 19F NMR relaxation methods, we will investigate the dynamics of the covalently bound DNA using novel substrates that are specifically labeled with 19F in rigid and dynamic regions of the DNA complex. (ii) Understand how the dynamic mobility of the topoisomerase IB DNA complex leads to recombinogenic DNA strand exchange reactions. The facile strand exchange reactions promoted by Topo also necessitate dynamic and thermodynamic destabilization of the DNA duplex near to the cleavage site. We will explore these key mechanistic aspects using novel NMR imino proton exchange measurements, and stopped flow kinetic and thermodynamic measurements. (iii) Develop chemical tools to rapidly profile the activities of topoisomerases and discover new ligands that modulate Topo function. A complete repertoire of high throughput topoisomerase screens will be developed to facilitate the discovery of novel small molecule topoisomerase inhibitors or poisons. These methods will provide new profiling tools for topoisomerase activity in clinical samples.

Public health relevance
RELEVANCE TO PUBLIC HEALTH DNA topoisomerase enzymes are essential protein machines that allow unwinding of over wound genomic DNA and also serve as important drug targets against cancer and bacterial infections. These studies aim to elucidate how the dynamic movement of these DNA‐bound machines allows DNA to unwind and drug molecules to bind. This understanding will provide a basis for the rational development of new more effective drugs.